NIDA INTERNATIONAL PROGRAM: RESEARCH AND TRAINING SUPPORT

"NIDA International Program: Research and Training Support

The NIDA International Program builds partnerships among individual scientists, research institutions, and national and international organizations to:

Promote international research collaboration
Sponsor research training fellowships
Exchange information on addiction science
he NIDA International Forum fosters international cooperative research and the exchange of scientific information by substance use researchers. Held each June in conjunction with the annual scientific meeting of the College on Problems of Drug Dependence (CPDD), the Forum highlights the range and quality of substance use and addiction research conducted around the world.

The Forum features a research symposium, a poster session, and network-building activities highlighting NIDA-supported and other international research on substance use. This unique scientific meeting allows participants to network with talented colleagues, learn about substance use research and policy issues in other countries, and discuss NIDA-supported fellowships and other programs that can support international